Evaluating the Impact of Telemedicine on Ambulatory Care

PROJECT SUMMARY/ABSTRACT
BACKGROUND: During the first six months of 2020, 10 million Medicare beneficiaries used telemedicine
services compared to only 134,000 during the first six months of 2019. Telemedicine policy changes during the
COVID-19 pandemic catalyzed a major transformation of ambulatory care delivery that is sustained—currently
1 out of 5 ambulatory care visits are performed through telemedicine. While state and federal agencies have
long positioned telemedicine as a means to improve health, post-pandemic telemedicine policymaking is
hindered due to the scarcity of evidence on the broad scale impact of telemedicine on healthcare access,
quality and costs. For instance, it is challenging to enact permanent telemedicine policies that facilitate the
equitable use of telemedicine without an understanding of patient, provider and market barriers that impede its
use. Furthermore, while widespread telemedicine use has the potential to improve clinical outcomes such as
preventable hospital admission rates, there is a lack of empirical data on this topic. Finally, while essential for
policymaking, the broad scale impact of telemedicine use on Medicare spending and utilization has not been
previously studied. The dramatic increase in telemedicine use as a result of healthcare policies enacted during
the COVID-19 pandemic provides an unprecedented opportunity to address these long-standing knowledge
gaps.
OVERALL STRATEGY: In this study, we propose using a contemporary, national cohort of Medicare
beneficiaries supplemented with detailed provider and market-level data to investigate factors associated with
telemedicine use, and the impact of telemedicine on ambulatory care outcomes and healthcare spending.
RESEARCH AIMS: 1) To identify patient, provider and market-level determinants of telemedicine use. We will
explore heterogeneity in telemedicine use across specific populations of interest, including beneficiaries that
are rurally located, elderly, racial/ethnic minorities, or socioeconomically disadvantaged. 2) To evaluate the
association between practice-level telemedicine use and hospital admissions for ambulatory care sensitive
conditions. 3) To evaluate the impact of clinician-level telemedicine use on 30-day total per capita costs.
IMPACT: Findings from this study will directly inform major areas of uncertainty and provide key evidence to
inform telemedicine policymaking.

Public health relevance
PROJECT NARRATIVE The coronavirus disease pandemic has led to rapid expansion of telemedicine services. Our study is focused on evaluating the impact of telemedicine adoption on ambulatory care for Medicare beneficiaries with three specific aims: (1) to identify provider- and market-level determinants of telemedicine use in the Medicare population, (2) to evaluate the association between practice-level telemedicine use and the rate of hospital admissions for ambulatory care sensitive conditions and (3) to evaluate the impact of clinician-level telemedicine use on Medicare spending and utilization. The proposed research will identify policy targets that can be used by policymakers and healthcare organizations to ensure the equitable, efficient, and effective expansion of telemedicine services.